Project 3-Cancer cell interaction with oncogenic type 1 collagen in PDAC

Project 3 -­ Abstract/Summary
The desmoplastic stroma, consisting of fibroblasts, extracellular matrix (ECM) and immune cells, is a defining
feature of human pancreatic ductal adenocarcinoma (PDAC), however its precise contribution to cancer
progression is still evolving. Type I collagen (Col1), a dominant component of PDAC desmoplasia, is uniquely
regulated in PDAC. Our preliminary studies uncovered that cancer cells produce a novel Col1 variant consisting
of alpha 1 chain (Col1a1) homotrimers. Genetic deletion of the oncogenic Col1 in cancer cells extends the overall
lifespan of PDAC genetically engineered mice (GEMs). Oncogenic Kras (Kras*), a central driver for PDAC, plays
a key role in determining the host response, including tumor immunity and metabolic adaptation. We discovered
that Kras* drives cancer cells’ production of oncogenic Col1 via epigenetic silencing of Col1a2. In contrast with
the classical Col1 heterotrimer produced by fibroblasts, oncogenic Col1 uniquely promotes PDAC initiation and
progression by influencing tumor metabolism and immunity. Col1 homotrimers bind to aα3bβ1 integrin on PDAC
cancer cells, a collagen receptor distinctly upregulated in mouse and human PDAC. This induces a sustained
activation of FAK, Akt and Erk1/2 when compared with Col1 heterotrimers, promoting cancer cells growth and
survival. Oncogenic Col1 also suppresses intratumoral T cells, and oncogenic Col1 deletion synergizes with anti-­
PD-­1 immune checkpoint blockade to suppress tumor growth and increase overall survival of PDAC GEMs.
Cancer cell-­directed oncogenic Col1 homotrimer signaling also enhances glycolysis and mTOR signaling,
supporting the metabolic reprogramming driven by Kras*. In Project 3, in close collaboration with Projects 1 and
2, we will define the role and regulation of Kras*-­induced oncogenic Col1 signaling in impacting tumor immunity
and metabolism. The proposed aims investigate Col1 homotrimers-­ aα3bβ1 integrin targeting, immunotherapy, and
anti-­metabolism strategies, as an informed combination treatment modality. Our preliminary data support the
feasibility and significance of this novel approach, and exploit a new vulnerability in PDAC signaling, with a
translational potential to inform new therapies for PDAC.

Public health relevance
Project 3 - Narrative The current treatment options for pancreatic cancer are not able to significantly impact the clinical outcome of our patients, so new strategies to unravel the biology of pancreatic cancer and identify new therapeutic modalities are urgently needed. We discovered a new vulnerability in pancreatic cancer cells that can be exploited to control cancer progression, consisting of a unique type I collagen variant and aα3bβ1 integrin signaling axis specific to cancer cells. This new target can be combined with therapies designed to unleash the anti- tumor immune response and suppress the altered metabolism of cancer cells in PDAC.